Cold Spring Harbor Laboratory Cancer Workshops

The Cold Spring Harbor Laboratory proposes to continue two courses in molecular
biology, molecular genetics and biochemistry, whose methodologies are central for
modern cancer research, to be held in 2023 - 2027. These short, intensive courses include
Mouse Development, Stem Cells & Cancer (three weeks) and Chromatin, Epigenetics
and Gene Expression (three weeks). Each course prepares the student to enter directly
into research that makes use of advanced and/or specialized techniques and concepts
that can be applied to studies of growth and regulation of normal eukaryotic cells and their
oncogenic counterparts. Each course has a different emphasis and serves a different
need. The course on Mouse Development, Stem Cells & Cancer trains scientists to study
gene regulation and development in the context of the whole organism, as well as mouse
models of human disease such as cancer. The course provides in intensive hands-on
introduction to engineering of mouse models, stem cell technologies and tissue analyses.
Lectures provide the conceptual basis for contemporary research in embryogenesis,
organogenesis in development and disease, embryonic, adult and induced pluripotent
stem cells and cancer biology. The course on Chromatin, Epigenetics and Gene
Expression aims to expose students to a broad array of methodologies to study gene
regulation, chromatin structure and epigenetics, including both well-developed and
cutting-edge methods, such as ChIP, CRISPR and Next Generation Sequencing. The
faculty is chosen on the basis of their contributions to and knowledge of the field covered
in each course. The faculty invite lecturers who have made significant contributions to
their fields and can provide up-to-the-minute reports on current research. The trainees
range from graduate students to senior investigators who are chosen by the course faculty
from a large number of applicants. Because of the short duration of the courses, senior,
as well as junior, individuals can attend and receive an intense period of training in an
environment remote from other demands on their on their time and attention. The courses
provide an unusual opportunity for scientists to retrain in another specialty or to apply the
work of a new field to their own research.

Public health relevance
Modern cancer research requires investigators who are skilled in a wide variety of advanced and innovative laboratory techniques and knowledge in both gene expression regulation and the fundamental of tissue/organ development and homeostasis. These Cold Spring Harbor annual three-week short courses offer specialized training in a residential setting that immediately impacts the progress of the trainees’ research. The courses also promote collaboration and exchange of ideas between faculty and trainees, and thus represent a significant and valuable investment towards accelerating cancer research by educating select cadres of researchers in the latest methods and concepts in these disciplines.